Bio-Behavioral and Community Engagement Core

Project Summary/Abstract (Bio-Behavioral and Community Engagement Core)
The HIV epidemic in the South, in Florida in general, and Miami is of critical concern. This epidemic is fueled by
relatively low prevention, treatment, and other biomedical and public health resources. The Bio-Behavioral and
Community Engagement Core (Core E) will continue to identify and seek to alleviate structural and systemic
barriers that have long impacted the HIV treatment and prevention continua in our region. The overall aim of this
core is to advance the HIV treatment and prevention continua of care and the ending the HIV epidemic initiatives
in South Florida. We propose to do this by fostering the development, implementation, and evaluation of
innovative, inter-disciplinary bio-behavioral, social sciences and community-engaged research and initiatives
that are heuristically guided by a Social Ecological Model Framework; thus, recognizing the need to implement
multi-level HIV prevention and treatment strategies. Core E has established strong HIV-related community
collaborations that will continue to expand the implementation of evidence-based approaches to HIV prevention
and care such as the University of Miami/Jackson Memorial Medical Center (UM/JMMC) Rapid Response Test
and Treat (TTRR); The University of Miami Research and Prevention of Infectious Diseases Program (RAPID);
The Infectious Diseases Elimination Act (IDEA Exchange); the Severe injection-related infection (SIRI) Team;
and the Transgender interest group. Core E has built extensive networks for effective community outreach and
engagement in the South Florida region. Core E will continue to provide scientific leadership and an infrastructure
that fosters integration and translation of behavioral, clinical, and basic research as well as expanding community
engagement in South Florida. These goals will be achieved through the following specific Aims: Aim 1. Provide
the necessary infrastructure to enable CFAR researchers to strategically advance the highest priority areas of
bio-behavioral investigation and inter-disciplinary collaboration among clinical, behavioral, social,
implementation and basic scientists. Aim 2. Promote active and meaningful bi-directional community
engagement by facilitating new and ongoing collaborations with Community Based Organizations (CBOs), Local
Federally Qualified Health Centers (FQHCs) and the Florida Department of Health (FDOH) to ensure their
participation and input in the development, implementation, monitoring, analysis, interpretation, completion and
translation of behavioral and social science research. Aim 3. Facilitate recruitment and retention of study
participants for research addressing populations in the greatest need of behavioral approaches addressing the
HIV treatment and prevention continua of care and ending the HIV epidemic initiatives.